EARLY INTERVENTION FOR CHRONIC OBSTRUCTIVE PULMONARY DISEASE

The goals of this multicenter study are to determine if smoking cessation affects the course of early chronic obstructive pulmonary disease and if treating hyper-reactive airways affects the course of early chronic obstructive pulmonary disease.